High-Definition Characterization of the Persistence and Perturbation of the HIV Reservoir: Project 1

SUMMARY
The primary goal of this Core is to administer the resources, both financial and participant samples, needed for
the successful completion of the Project and Core research aims. Specifically, this core will provide the
following services: 1) Provide administrative and budgetary oversight of the Projects and Cores; 2) Plan and
arrange for regular team Program leadership meetings and Program scientific meetings; 3) Facilitate the
communication and exchange of data between Projects and Cores; 4) Produce and submit annual progress
reports, and the final progress report; 5) Assist in the speedy execution of institutional review board
applications and material transfer agreements; and 6) Work closely with outside collaborators and the AIDS
Clinical Trials Group to coordinate the identification, receipt, and storage of participant samples. In addition,
this Core will work closely with outside collaborators and the AIDS Clinical Trials Group to coordinate the
identification, receipt, and storage of participant samples. The Administrative and Sample Collection Core will
facilitate institutional regulatory approval and material transfer agreements.

Public health relevance
NARRATIVE The primary goal of this Core is to administer the resources, both financial and participant samples, needed for the successful completion of the Project and Core research aims. Specifically, this core will provide administrative and budgetary oversight of the Projects and Cores, organize scientific meetings, produce and submit annual progress reports, assist in the speedy execution of institutional review board applications and material transfer agreements; and coordinate the identification, receipt, and storage of participant samples.